Engineered Glioblastoma-specific T cells using Immunostimulatory Photothermal Nanoparticles

PROJECT SUMMARY
The goal of this STTR Phase II application is to advance the development and translation of IB-T cells, a
personalized and multi-targeted autologous adoptive T cell therapy (ATCT) for glioblastoma (GBM). This
project is a partnership between ImmunoBlue (PI: Dr. Elizabeth Sweeney) and George Washington University
(GW) (PI: Dr. Rohan Fernandes). GBM is the most common primary brain tumor, and is associated with a
dismal prognosis and five-year relative survival of 7.1%. In response to this need, we have developed
photothermally activated IB-T cells, a personalized ATCT targeting multiple tumor-derived antigens in GBM. IB-
T cells are generated by administering Prussian blue nanoparticle-mediated photothermal therapy (PTT) to
patient tumor cells excised during surgery. PTT elicits immunogenic cell death (ICD) and facilitates the release
of tumor antigens and immune adjuvants. These unique tumor antigens are used to expand personalized
tumor-specific IB-T cells in the presence of autologous dendritic cells (DCs). For our Phase 1 clinical trial, we
envision administering IB-T cells as an adjuvant therapy directly into the tumor bed through an Ommaya
reservoir after standard-of-care surgery. In our STTR Phase I studies, we established the feasibility and
efficacy of developing autologous GBM-specific IB-T cells with our PTT platform using peripheral blood and
GBM tumor samples from patients. Specifically, we illustrated that PTT-treated GBM cells facilitate the
generation of potent and personalized GBM-specific IB-T cells in an antigen-agnostic manner (n=6 patients).
These patient-specific IB-T cells exhibited functional specificity toward the tumor cells, as measured by IFN-ɣ
ELISpot and cytotoxicity assays in vitro. In contrast, non-specific T cells from the same patients did not respond
to autologous tumor cells. In this STTR Phase II study, we seek to address scale-up, manufacturing, and safety
considerations to ensure reproducibility, low toxicity profiles, and GMP compatibility of IB-T cells, as we
prepare to submit an IND application with the FDA. In Aim 1, we seek to develop GMP manufacturing protocols
and perform engineering runs for IB-T cell products (n=4). We will initiate technology transfer with the GW
GMP facility to translate our IB-T manufacturing protocol into GMP compliance, and establish a quality control
program that defines the critical quality attributes (CQAs) of IB-T cells and release testing criteria. In Aim 2, we
will test the efficacy of GMP-manufactured IB-T cell products in orthotopic PDX models generated in NSG mice
in vivo. Next, we will perform IND-enabling studies, including in vitro off-target and autoreactivity testing with
autologous products, and in vivo toxicity and biodistribution testing using syngeneic murine models (i.e. GL261
and SB28). Together, ImmunoBlue and GW have the personnel and resources to undertake the studies
proposed in this project, including experts in neuro-oncology, cell therapies, and immunoengineering, and an
in-house GMP facility available at GW. Importantly, this project will take ImmunoBlue’s IB-T cell therapy from
preclinical validation to clinical readiness, setting the stage for a Phase 1 clinical trial for GBM patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it could make available an effective and safe T cell therapy for glioblastoma (GBM), the most common primary brain tumor, with a poor five-year relative survival rate of 7.1%. Successful completion of this Phase II project will take ImmunoBlue’s IB-T cell therapy from preclinical validation to clinical readiness, setting the stage for a Phase 1 clinical trial for GBM patients. Together, these milestones will advance the translation of the IB-T cell platform for commercial use.